Supplement in support of Diversity in Genetic studies of IBD and functional studies of IBD genes.

Project Abstract
The inflammatory bowel diseases (IBD) are characterized by chronic relapsing inflammation of
the gastrointestinal tract. Crohn’s disease (CD) (MIM 266600) and UC (MIM 191390) are the
two main subtypes of IBD. The NIDDK Inflammatory Bowel Disease Genetics Consortium
(IBDGC) was established in July 2002 for the purpose of identifying genetic variation
predisposing to IBD. The Montreal-Boston Collaborative IBD Genetic Research Center
(GRC), is a founding member of the IBDGC. In the current proposal, the Boston group will have
two Specific Aims:
SA#1: To characterize the genetic architecture of IBD phenotypes within populations
currently underrepresented in IBD genomic research. OBJECTIVE: To employ local
ancestry decomposition to identify variants uniquely enriched in US admixed samples to identify
previously overlooked genetic risk factors contributing more substantially to IBD in Hispanic and
African-American populations.
SA#2: Analysis of the newly identified CD gene PDLIM5 and its splice region variant and
their impact on epithelial functions. OBJECTIVE: To determine the function of a newly
identified CD gene and placing it in the biological context of other IBD genes using patient-derived
materials, organoids and hiPSC-based models.
We are committed to including both sexes in our genetic and functional studies, including sex as
a variable in our data collection, analysis of results, and reporting of findings. This includes patient-
derived cellular models (e.g. hiPSC-derived lines). We will also ensure that the experiments are
done on diverse genetic backgrounds and determine if this impacts the effect of perturbation or
baseline behavior of the assay and/or model.

Public health relevance
Project Narrative This project aims to identify the genetic causes of the inflammatory bowel diseases (IBD) known as Crohn’s Disease (CD) and ulcerative colitis (UC), particularly in populations currently underrepresented in IBD genetic studies. We further aim to determine biological impact of the genetic risk factors to better understand disease processes.